Mechanism Based Design of Ce(IV) Mediated Reactions

DESCRIPTION (provided by applicant): Functional group oxidations and oxidative bond-forming reactions are ubiquitous in organic synthesis and vital to the construction of biologically active compounds. During the past several years, a number of important synthetic methods have been developed that proceed through an initial single electron oxidation. The mechanistic studies presented herein will focus on understanding and improving two important synthetic platforms that utilize single electron oxidation as a critical step in bond-forming reactions: 1) oxidative enolate heterocoupling, and 2) organo-SOMO activation. It is our hypothesis that the high distribution of heterocoupled products obtained in oxidative enolate heterocoupling reactions is in part a consequence of lithium enolate heteroaggregates formed from deprotonation of carbonyl precursors. To study this system in detail, the rates of oxidation of a series of enolates will be measured by stopped-flow spectrophotometry and ReactIR and compared to the thermodynamic ease of oxidation of these substrates as measured by cyclic voltammetry. In all of these studies, the impact of enolate countercation, oxidant, and solvent will be evaluated. NMR studies will be employed to determine the distribution of aggregates contained in solution that are derived from deprotonation of equimolar mixtures of carbonyl precursors. These data will be used to assess how both heteroaggregate distributions and kinetics of reaction impact product distribution in oxidative coupling reactions and provide an important guide in the rational design of high-yielding enolate heterocoupling reactions. In the second portion of the proposed work, initial studies of organo-SOMO activation show that the concentration of water not only impacts intermediate enamine formation, but also attenuates the solubility of Ce(IV). The interplay between these two factors is critical for reaction success. To examine this system, mechanistic studies including reaction progress kinetic analysis and spectrophotometry will be used to assess the impact of oxidant, solvent, and catalyst structure in two important organo-SOMO-activated processes: allylation and arylation. Additionally, the importance of oxidant phase-transfer and the relationship between reaction rate and enantioselectivity will be determined. The information acquired from these studies will be used to guide the development of more efficient organo-SOMO-activated processes. Overall, these rigorous mechanistic studies will catalogue the factors critical for concise reaction design enhancing the use of oxidative enolate heterocoupling and organo-SOMO-activated methods in the synthesis of medically important compounds. PUBLIC HEALTH RELEVANCE: The work described in this proposal will use our mechanistic understanding of Ce(IV)-based oxidants as a benchmark to understand and improve two important synthetic platforms that utilize single electron oxidation as a critical step in bond-forming reactions: 1) oxidative enolate heterocoupling, and 2) organo-SOMO activation. The proposed studies presented herein will provide synthetic chemists with mechanistic information crucial for the development of high yielding procedures valuable for the synthesis of complex molecules important in medicine.

Public health relevance
The work described in this proposal will use our mechanistic understanding of Ce(IV)-based oxidants as a benchmark to understand and improve two important synthetic platforms that utilize single electron oxidation as a critical step in bond-forming reactions: 1) oxidative enolate heterocoupling, and 2) organo-SOMO activation. The proposed studies presented herein will provide synthetic chemists with mechanistic information crucial for the development of high yielding procedures valuable for the synthesis of complex molecules important in medicine.